Developmental Research Project Program (DRPP)

Developmental Research Project Program Summary
The overarching goals of the Developmental Research Project Program (DRPP) are: 1) to continue to increase
biomedical research capacity in Kentucky by assisting faculty at the primarily undergraduate institutions (PUIs)
become competitive for independent NIH research funding, and 2) to provide the highest quality research training
to undergraduate students. To achieve these goals, the DRPP provides training, mentoring, and research
funding to PUI investigators to be successful in competing for new and competing renewal NIH R15 and/or R16
awards. These two award mechanisms serve our dual purposes of supporting high quality faculty research while
providing outstanding hands-on research experiences for undergraduate students. Modeled after NIH R15/R16
application guidelines and review procedures, the DRPP supports and manages two research funding
mechanisms (Pilot Project (PP) and Research Projects (RP)) from solicitation of proposals through scientific
review and approval. The DRPP also provides grant writing workshops, one-on-one mentoring, site-visits, and
other consulting services. While primarily aimed at early stage investigators, the PP and RP grant mechanisms
provides support to productive investigators at all stages of career development. Complemented by other
research support and training programs provided by the Administrative and Data Science Cores, the DRPP aims
to build a sustainable statewide biomedical research network.